Innate immune defenses against a cytosolic capsule

Abstract
All pathogens evolve virulence mechanism to evade immune responses, especially those that would
most directly counteract their virulence. Simultaneously, host species evolve defenses against pathogenic
virulence properties. This never-ending competition is an example of the Red Queen’s evolutionary race.
However, at each point in the competition one side may have the upper hand. We have often found that
pathogens have the upper hand over immune defenses, which allows the bacterium to replicate and cause
disease until an adaptive immune response turns the tide. In contrast, our lab has found that environmental
bacteria often have strong virulence potential, but lack the evasive properties of host-adapted pathogens.
These “Red Pawns” are readily eliminated by immune defenses. In this grant, we discover a new Red Pawn
environmental pathogen that has a strong virulence potential conferred by an extracellular polysaccharide
capsule – however, this virulence benefit comes at the cost of being readily detected by immune sensors that
organize successful countermeasures against the capsule.
Many bacteria produce extracellular polysaccharides that form a capsule. Such capsules allow bacteria
to evade the immune response. Capsules can prevent complement deposition to allow bacteria to evade the
extracellular complement deposition that could opsonize bacteria and attract phagocytes from the immune
system. Capsules also shield other cell surface molecules that allow phagocytes to bind and phagocytose
bacteria. Thus, capsules have been a classical virulence trait that allows bacteria to replicate in the
extracellular space by resisting extracellular defenses. However, extracellular polysaccharides have also been
identified on bacteria that are invasive and replicate intracellularly. Here we study how intracellular capsule
provides a virulence benefit to an intracellular environmental bacterial pathogen, and how the host immune
system senses this virulence trait and responds to counteract the virulence of the bacterium.

Public health relevance
Project Narrative Some bacterial pathogens use a polysaccharide capsule to allow them to evade the immune response. Here we investigate how one such capsule is detected by a type of immune sensors. We study how this detection organizes an immune response that clears the infection.